Core A. GENOMICS CORE

The 01 Genomics Core will be a resource that actively collaborates with project investigators by providing advanced and specialized methods in genotyping and high-throughput sequence analysis to assist in identifying new human genetic defects that cause recessive osteogenesis imperfecta. The Core will also provide capabilities to validate genes identified in the initial screen by analyzing segregation patterns of the mutations in the index families and sequence analysis in additional patients with 01 phenotypes. The Cohn laboratory has had a longstanding working collaboration with all of the other members of the Program Project team, including specific studies of osteogenesis imperfecta. Because the methods to be used are well established within the laboratory and apply broadly to the proposed projects, consolidating the gene discovery methodologies in the Core (rather than each individual project) will provide both efficiency and cost savings.

Public health relevance
RELEVANCE (See instructions): Gene discovery in human genetics is now driven by next generation sequencing. This Core will provide this service to help identify new genes that cause osteogenesis imperfectacta.